Biomarker Core

CORE F – PROJECT SUMMARY/ABSTRACT
The Biomarker Core (Core F) of the ADRC will provide services, resources and expertise in the vascular, blood-
brain barrier (BBB), neurovascular unit (NVU) and standard Alzheimer’s disease (AD) amyloid-β (Aβ) and tau
biomarkers for USC ADRC and outside investigators. This will support the central theme of our ADRC to
elucidate vascular contributions to cognitive impairment and AD, and the role of cerebrovascular system,
vascular and metabolic risk factors (VMRF), and NVU in cognitive decline and the pathogenesis of dementia and
AD. The Biomarker Core F has expertise in developing novel vascular, BBB and NVU cell- and system-specific
biomarkers in biofluids in addition to AD biomarkers (e.g., Aβ, tau, pTau). Core F will determine simultaneously
in the cerebrospinal fluid (CSF) and plasma in participants of the primary ADRC vascular cohort study (VCS)
biomarkers of vascular and BBB injury, other NVU biomarkers (e.g., astrocytes, microglia, inflammatory
response, and neuronal injury) and AD Aβ, tau, and pTau biomarkers. Core F will also conduct Aβ and tau
measurements and APOE genotyping in all ADRC participants that consent to CSF and/or blood collection.
Existing strengths of our core include i) decades of experience and knowledge in studying the BBB,
cerebrovascular system, and NVU; ii) experience in developing novel vascular/BBB biomarkers, as for example
new, sensitive assays for novel analytes of interest including sPDGFRβ (pericyte injury marker), pleiotrophin
(PTN, a growth factor expressed by brain capillary pericytes), cyclophilin A, ferritin, active TGF-β1, as well as Aβ
and tau oligomer assays.; iii) providing reliable and simultaneous measurements of multiple NVU biomarkers in
biofluids for all pilot data analyses of ADRC investigators using the ultrasensitive electrochemiluminescent Meso
Scale Discovery (MSD) multiplex platform; and iv) on-going multi-year collaborations with several USC ADRC
investigators including Drs. Chui, Toga, Harrington, Ringman, Wang, Nation, Yassine, Braskie, Pa, and others,
and several external investigators working in the AD field (resulting in numerous publications). Core F will also
generate and maintain a BioBank of peripheral blood mononuclear cells (PBMCs) to be sent and deposited to
the NIH National Centralized Repository for Alzheimer’s Disease and Related Dementias (NCRAD), and of
induced pluripotent stem cells (iPSC) for ADRC investigators’ working on in vitro models of NVU, BBB and/or
‘brain on a chip’. Under the leadership of Dr. Zlokovic and the resources available at USC Zilkha Neurogenetic
Institute, Core F will 1) coordinate and standardize biofluid collection, processing, storage and distribution; 2)
assay CSF and plasma for vascular, BBB, NVU and standard AD biomarkers and conduct APOE genotyping; 3)
provide technological developments; 4) generate and maintain a BioBank of PBMCs and iPSCs; and 5) facilitate
data management, requests, and distribution to USC ADRC investigators to support our ADRC’s scientific goals.
.